US POINTER Neuroimaging Ancillary Study

Project Summary / Abstract
The U.S. study to PrOtect brain health through lifestyle INTErvention to Reduce risk (U.S.
POINTER) is a $35M Alzheimer's Association-sponsored multisite randomized clinical trial
investigating the influence of a multidomain lifestyle intervention (exercise, diet, cognitive stimulation,
health coaching for risk factor reduction) on 2yr cognitive trajectories in older adults at increased risk
of dementia. POINTER was modeled after Finland's FINGER trial that showed a greater cognitive benefit for
those assigned to a multidomain lifestyle intervention group versus health education. POINTER will use a
similar two-group study design. The health education (“self-guided”) group will receive information and support
through twice yearly group meetings to encourage healthy lifestyle practices. The higher-intensity (“structured”)
lifestyle intervention group will receive frequent coaching and group meetings to encourage aerobic exercise
and cognitive training 4 days/week, adherence to a modified Mediterranean diet, and cardiovascular risk
reduction through increased medical monitoring. Based on the successful FINGER results, the structured
group is predicted to show the greatest benefits on 2yr cognitive trajectories given the high intensity of the
intervention and the potential for synergistic effects across lifestyle domains.
Lacking from the POINTER design, however, are neuroimaging measures to investigate
intervention effects on underlying Alzheimer's disease (AD) and cerebrovascular pathophysiology.
This proposed imaging ancillary study leverages unique resources provided by the parent trial to examine
whether changes in lifestyle can protect brain health and alter AD trajectories. The study will assess these
intervention effects on changes in AD and cerebrovascular pathophysiology. It will also examine
whether these biomarkers at baseline predict cognitive response to the intervention, which has
important implications for precision medicine in identifying those most likely to benefit from this approach. AD
and cerebrovascular pathophysiology will be assessed with PET imaging (baseline, 2yrs) to measure beta-
amyloid and tau burden, and MR imaging (baseline, 1yr, 2yrs) to measure brain morphometry, white
matter hyperintensities and microstructural integrity, and cerebral blood flow.
An in-depth analysis of lifestyle changes on disease biomarkers has significant implications for public
health given the current weight of evidence showing favorable effects of lifestyle on brain health in
older adults that overshadow the results of all other pharmacological treatments to date. Moreover,
lifestyle modification is an affordable and accessible approach with health benefits that extend beyond brain
health. A critical and clinically relevant feature of the POINTER trial is its recruitment approach which targets a
community-based and geographically and racially/ethnically diverse sample, ensuring that the
intervention will be applicable to a large proportion of older individuals.

Public health relevance
Project Narrative The POINTER imaging ancillary study leverages the rare opportunity provided by the ongoing POINTER multidomain lifestyle intervention trial to examine intervention effects on changes in Alzheimer's disease and cerebrovascular pathophysiology, measured with MRI and PET neuroimaging. This study also aims to determine whether these biomarkers at baseline predict cognitive response to the intervention, which could inform precision medicine approaches to healthcare. The proposed study is responsive to the 2018 NIA Research Summit recommendations that encourage rigorous investigations of lifestyle change as a disease- modifying therapeutic strategy to prevent AD and related dementias.